Center for Demography of Health and Aging

Project Summary
This is a proposal for renewal of the Center for Demography of Health and Aging (CDHA) at the University of
Wisconsin-Madison. CDHA supports high-impact, innovative research and the production of multiple shared
data resources that benefit the broader scientific community. It also facilitates career development for emerging
scholars and enables investigators to pursue new scientific opportunities and collaborations. CDHA’s
intellectual community brings together 121 affiliates from 30 departments across the social and health sciences
who pursue research in five signature themes: (1) Aging trajectories and health disparities across the life
course; (2) Biodemography; (3) Place, health, and aging; (4) Health policy and health services; and (5)
Demography of dementia and cognition, a new theme and emerging area of research excellence for CDHA.
These themes are a product of our traditional strengths, a growing number of affiliates who bring both breadth
and depth of expertise to the study of aging and health, and a vision for impactful future research contributions.
CDHA’s research has evolved jointly with the growth of the Wisconsin Longitudinal Study and multiple other
locally-led major population-based surveys as well as new studies centering NIH’s Health Disparity Priority
Populations. CDHA is an autonomous research unit within the College of Letters & Science. It is supported by
a well-developed research infrastructure in administration, computing facilities and data library, and
dissemination capacity. CDHA’s Administrative Core (A) provides governance and administrative support and
coordination for the Center as a whole. The Program Development Core (B) supports faculty, staff, and
research assistants engaged in pilot research projects with a track record of generating substantial subsequent
NIA support. It puts a particular emphasis on career development and mentorship for emerging scholars, as
well as on supporting innovation in population-based aging research. The Communication and Dissemination
Core (C) manages CDHA’s website and multiple digital, print, email and social media platforms to
communicate CDHA activities and disseminate research findings and opportunities to internal and external
affiliates and diverse audiences in academia, policy, and the public sphere. The External Network Core (D)
develops innovative research networks within and beyond CDHA by organizing conferences, workshops, and
seminars on critical themes; sponsoring novel modes of local data dissemination and new data user training;
and pursuing focused outreach and professional development activities. Finally, the Remote Data Enclave
Core (F) supports the analysis of restricted-use data resources under secure conditions and integrates with a
state-of-the art Federal Statistical Research Data Center facility on the UW-Madison campus.

Public health relevance
Project Narrative The Center for Demography of health and Aging (CDHA) fosters innovative research on the biological, social, economic, and geographic factors that impact longevity and physical, mental, and cognitive health in later life. CDHA affiliates produce numerous shared data resources that benefit the broader scientific community, and the center supports emerging scholars and established investigators in pursuing new scientific opportunities and collaborations. CDHA’s intellectual community brings together 121 affiliates from 30 departments across the social and health sciences, supported by administrative, communications, and data services that organize and manage a broad array of research and training activities.